Oregon Worker Illness and Injury Prevention Program

[unreadable] DESCRIPTION (provided by applicant): The Oregon Fatality Assessment and Control Evaluation program (OR-FACE), beginning in late 2002, has successfully implemented the NIOSH objective for state-based surveillance, investigation, assessment, and outreach in order to prevent future occupational fatalities. With 2 years of complete data on fatalities, the ORFACE team is already implementing a variety of intervention strategies to promote safety in priority areas. The expanded fatality surveillance project allows the continued development of training materials, education [unreadable] and outreach, using the results of fatality surveillance, investigation and assessment. The research plan is designed to reflect the key components of successful injury surveillance and prevention programs. A multi-agency, multi-disciplinary approach has been used to identify occupational fatalities in the state, to investigate work situations where fatalities occur, to analyze root and contributing causes, and to [unreadable] formulate and disseminate prevention strategies to workers, employers, insurers, and health & safety [unreadable] professionals. The research plan is designed to maintain the current structure of OR-FACE activities in surveillance, investigation, assessment, and outreach related to traumatic occupational fatalities, while expanding prevention activities that target high-risk activities in specific industries and occupations for intensive intervention which may include training, education, engineering controls, and policy recommendations. The expanded fatality surveillance project will be conducted as a collaborative effort among academic researchers, industry experts, state, local and federal agencies, and a network of business, labor, community and professional contacts. The purpose of this study is to identify and describe all work-related deaths that occur in Oregon during the study period. Information collected during the study will be used to develop methods to prevent future deaths by understanding the underlying risk factors and cause of work-related deaths. [unreadable] [unreadable] [unreadable]